Adipokine-enriched brown adipocytes for treating polycystic ovary syndromes

Abstract
Polycystic ovary syndromes (PCOS) affect 6-18% of reproductive age female, representing the most common
endocrine disease in this population. PCOS causes gynecological, dermatologic and metabolic comorbidities,
and also imposes long-term risks of diabetes mellitus type 2 (T2D), cardiovascular diseases (CVD) and
psychiatric problems including severe depression. PCOS is related to complex hormonal dysregulations such as
hyperandrogenism, hyperinsulinemia and gonadotropin dysregulation. And PCOS is commonly associated with
metabolic disorders, with 50-70% of PCOS patients showing insulin resistance and 10% with T2D, implying a
potential causative interlinks between them. Current standard of care includes life style changes and multiple
lines of medications with aims to relieve symptoms. Medications usually have moderate success rates, and have
limited effects on long-term risks of T2D, CVD and psychiatric problems. We propose to use metabolically active
brown adipocytes, which have high secretion of endocrine factors including but not limited to adiponectin, to treat
PCOS. The working mechanisms may involve the both metabolic activities and endocrine secretions of brown
adipocytes, which are previously extensively studied in metabolic programs and now indicative of clinical benefit
for PCOS treatment as well. The present Phase I SBIR project aims to test the hypothesis based on our bank
currently containing 150+ cell populations from donor, and evaluate clinically relevant efficacy of the selected
cells in an established mouse model.

Public health relevance
Project narrative PCOS affects 6-18% of reproductive age female with up to 5 million patients in the United States. It is one of the most common reproductive endocrine diseases. PCOS has a broad set of chronic symptoms related to hormonal imbalance such as hyperandrogenism, hyperinsulinemia and gonadotropin dysregulation. PCOS causes menstrual acyclicity, ovarian cysts, anovulation, infertility, hirsutism and acne, and also importantly, the long-term risks of developing insulin resistance, diabetes mellitus type 2 (T2D), hyperlipidemia, cardiovascular diseases (CVD) and psychiatric problems including severe depression. We propose to use metabolically active brown adipocytes, which have high secretion of endocrine factors including but not limited to adiponectin, to treat PCOS symptoms and resolve long term risks of developing T2D and CVD.